Shared Resource Management

PROJECT SUMMARY: Shared Resource Management
Christina Harrington, Ph.D., Associate Director of Shared Resource Management
The Knight Cancer Institute (KCI) supports six Shared Resources, which provide critical technologies, services,
and expertise required for KCI Member research and for the advancement of the KCI Strategic Plan priorities of
Precision Oncology and Precision Early Detection. All six Shared Resources (Advanced Multiscale Microscopy,
BioLibrary and Pathology, Biostatistics, Flow Cytometry, Integrated Genomics, and Proteomics) are widely used
by KCI Members. Key strengths of the KCI Shared Resources are the incorporation of University cores into
coordinated Shared Resources for cancer research support, robust University investment in technology
acquisition and core operations, and a commitment to communication and coordination among Shared
Resources and with KCI Members and Program Leaders. During the current funding cycle, all of the Shared
Resources acquired new technologies and expanded their services and expertise to meet KCI research needs.
The goals of Shared Resource Management are to ensure the continued success of the KCI Shared Resources
in achieving outstanding levels of performance, to facilitate communication and coordination among Shared
Resources, KCI Research Program Leaders and KCI Members, and to plan for emerging technologies and new
Shared Resources that will meet evolving needs. Shared Research Management is led by the Associate Director
for Shared Resources in partnership with the Associate Director of Administration; together, they provide
scientific, Shared Resource operation and administrative expertise. Shared Resource Management works to
ensure that high quality, cost-effective and reliable services are available to KCI Members and that appropriate
policies are established for access and use. Shared Resource Management performs annual user satisfaction
surveys, tracks usage, coordinates annual evaluations by the KCI Shared Resource Advisory Committee, and
coordinates planning for new Shared Resources and technologies. Shared Resource Management works with
the Shared Resource Advisory Committee, KCI Members, and Shared Resource Directors to identify current
and future needs for specialized technologies and essential services and presents recommendations for new
Shared Resources and critical technologies to KCI Senior Leadership for evaluation and decision. A potential
new Shared Resource for Digital Technologies and Biomarkers to collect, track, and analyze health data from
cancer patients is being considered in collaboration with the new Center for Biomedical Data Science being
established at KCI. Shared Resource Management will continue its oversight and support of the established
Shared Resources and the partnerships of the Shared Resources with other KCI platforms, with the overarching
goal of contributing to successful research outcomes for KCI Members.